Black Men's Brain Health and Aging, Alzheimer's Disease and Related Dementias: Life Course Perspectives

The United States has invested significant resources through innovative research to address the profound effects of Alzheimer’s Disease, and Alzheimer’s Disease and Related Dementias (AD/ADRD) on families and society, but Black men historically have not experienced the full benefits of scientific advances from that research. For example, non-Hispanic Black men have diminished health and increased morbidity due to preventable diseases (e.g., cardiac, diabetes, high blood pressure) and shorter life expectancies than their White male counterparts Additionally, elderly Black men are more likely to fall and sustain a TBI than whites, which increases the subsequent vulnerability of brain health and risk of dementia. Similarly, Black American men might be at increased risk for later-life neurological disorders associated with exposure to brain injury from contact sports participation, military service, and other sources. Although the prevalence of AD/ADRD in Black Americans is two to three times higher than in non-Latino White Americans, a complete understanding of the causes of this profound health differences remains elusive. The lack of a highly trained, multidisciplinary scientific workforce that addresses the full range of biological, biomedical, behavioral, and health sciences approaches to AD/ADRD health differences research hinders innovation among this population. During this five-year renewal conference series, leading multidisciplinary national and international scholars will come together with emerging investigators to address specific cultural, social, and behavioral factors that contribute to some individuals in this population being more cognitively resilient and experience a reduced risk of developing Alzheimer’s disease than others. Scholars will enhance the NIA Health Disparities Research Framework (HDRF) with the inclusion of empirically based factors that are responsive to the Black male experience, as well as focus on efforts to improve recruitment and retention strategies for participation from this population in aging research. An essential feature of the conference series will be to engage community stakeholders (e.g., NFL Alumni Association, Global Sports Institute, Black Men’s Health Clinic, Beloved Community Services Corporation) in multiple aspects of the conference design, planning, and implementation including the selection of scientists and clinicians, providing feedback on conference presentations, and dissemination. Planning, implementation, participation, and evaluation of the conference will include Black men. The aims of the renewal conference series are: (1) Host five multidisciplinary conferences that address knowledge gaps, and identify future priorities in inclusion science, AD/ADRC clinical trials, cognitive reserve/resilience, aging, and AD/ADRDs health differences life course research among Black men; and (2) Train a culturally competent workforce that can advance the science and practice of lifespan brain health optimization for Black men, and to stimulate new life course research focused on brain health, cognitive aging, and AD/ADRDs among Black men. These initiatives align with the goals of the NIA Division of Behavioral Health and Society Research (BSR), to achieve health, and improve the health of all groups.

Public health relevance
Project Narrative (revised) Despite heightened awareness, stark differences in U.S. population-level health outcomes continue to persist. Black men suffer high rates of biological, psychological, and sociocultural vulnerabilities throughout the life course that could uniquely and substantially increase their Alzheimer’s Disease and Alzheimer’s Disease Related Dementias (AD/ADRD) risk. Building on the success from the first award period to advance health differences research via focused and collaborative attention on the increased representation of Black men in biomedical research, inclusion science, and better integration of their unique biopsychosociocultural risk and resilience factors into models of brain health, cognitive aging, and AD/ADRD across the life course.